Increasing Access and Developing Predictors for Colorectal Cancer Screening for Minority and Medicaid Clients

ABSTRACT African Americans have 22% higher incidence and 49% higher death rates from CRC than any other ethnic/racial group. Similarly, lower socioeconomic status (SES) is also associated with higher CRC incidence and mortality. Both of these groups are overrepresented in Medicaid populations. Screening colonoscopy is a cost-effective cancer prevention and control strategy, leading to CRC prevention (e.g., removal of precancerous polyps), earlier CRC detection and therefore higher survival rates. For patients preferring or needing alternatives, fecal tests are reliable alternatives (e.g., FIT). However, numerous individual and structural barriers often reduce client adherence to screening guidelines resulting in “gaps in care,” increasing costs of treatment and lower quality metrics (e.g., Medicare Star and HEDIS® scores) for the health insurance companies and providers. Insured, non-adherent patients are considered a strategic priority for insurers. The mission of Witness CARES, LLC, is to help improve people's lives by facilitating use of health care. The product to be developed in this STTR Phase I study is a specialized set of services and electronic prototype tool (i.e., WC Services) to optimize and predict CRC screening for Medicaid clients based on our behavioral research, intervention development and delivery through a not-for-profit organization. We will provide personalized, culturally/racially-customized services for insured client end-users while improving national metrics and cost-effective access for the health insurance company and health care provider customers. The technological innovation is development of a computer-based assessment tool (i.e., Screening Engagement Model) allowing us to tailor messaging and type of screening test (FIT or colonoscopy) to client preferences, with the goal of increasing rates of screening for these clients and reducing colonoscopy no-shows for GI facilities. Successful creation of this product will reduce gaps in care for health insurers and reduce disparities in CRC mortality. To move forward, we need to 1) prove that this product can be delivered outside an individual clinical setting and significantly reduce gaps in care; and 2) develop a predictive model for determining which patients are best served by navigation to colonoscopy versus a stool test. The goal of this Phase I application is to prove the feasibility and small scale pilot efficacy of WC Services to increase CRC screening. We propose the following specific aims: Aim 1: Test the feasibility of WC Services to achieve CRC screening for non-adherent Medicaid clients. Milestone 1a: Achieve either colonoscopy or stool screening by a minimum of 130 of 200 (65%) patients contacted. Milestone 1b: Produce a new prototype to test in Phase II. Aim 2: Develop an algorithm for predicting CRC screening outcomes. Milestone 2a: Develop models based on existing R01 data to predict intent and CRC screening behaviors. Milestone 2b: Revise this R01 model with new measures collected prospectively from 80% of clients contacted (n=160) to identify likelihood of stool test v. colonoscopy completion. Milestone 2c: Develop a revised prototype into a complete WC Services product.

Public health relevance
NARRATIVE The proposed study is relevant to public health because it studies the feasiblity of developing a business model to increase colorectal cancer (CRC) screening for African Americans and lower income Medicaid/Medicare patients who have an excess incidence and mortality rate from this disease. The proposed study is relevant to the NIH mission pertaining to support of knowledge and research that will help reduce CRC health disparities. Moreover, demonstrating the commercial potential for these services provides the opportunity to significantly increase dissemination of effective, evidence-based outreach and navigation to reduce CRC disparities.